Novel pathogenesis of LVNC

PROJECT SUMMARY
Left ventricular noncompaction cardiomyopathy (LVNC) is a rare morphological abnormality of the
myocardium occurred during early heart development characterized by excessive trabeculae with deep inter-
trabecular recesses, but thin free wall. LVNC is classified as the third most common cardiomyopathy, with a
prognosis ranging from asymptotic to preterm death, cardiac arrythmia, and heart failure. Recent advances
in imaging technology have led to increased detection of LVNC, although the underlying cellular and molecular
causes remain elusive. Previous studies have mainly focused on intrinsic defects in myocardium, yet
mounting evidence also suggests that LVNC is associated with impaired function of non-muscle cell types in
the developing heart including cardiac endothelial cells (CECs), which are highly heterogenous, composed of
both endocardial and coronary endothelial cells. Previous studies have shown that both endocardial
endothelial cells (EECs) and coronary endothelial cells (CoECs) are required for proper trabecular and
compact myocardial morphogenesis, although the underlying cellular and molecular mechanisms remain
elusive. We discovered that global knockout (KO) of Zip8, a zinc ion importer, results in LVNC and preterm
lethality in mice, suggesting that Zip8 plays indispensable roles during myocardial trabeculation and
compaction. However, it is unclear through what cellular and molecular mechanisms Zip8 impacts myocardial
formation. Using various Cre driver mouse lines, our preliminary data demonstrated that only endothelial
deletion of Zip8 recapitulated the LNVC phenotype seen in global Zip8 KO hearts. Surprisingly, the
proportions of EECs and CoECs in Zip8 endothelial KO (Zip8eko) hearts were skewed; compared to control
littermates, EECs were significantly more abundant, whereas CoECs were less abundant in Zip8eko hearts.
We also found that certain paracrine growth factors such as Insulin-like growth factor 2 (IGF2) were
significantly upregulated in Zip8eko hearts, which is consistent with an increased EEC population, and may
contribute to the hypertrabecuation phenotype. Conversely, we also found that coronary vessels were
significant fewer in Zip8eko hearts, accompanied by decreased VEGF signaling, a major angiogenic pathway
during early heart formation. These results are consistent with a reduced CoEC population, which together
account for the noncompaction phenotype. Accordingly, we hypothesize that Zip8/Zn in CECs orchestrates
myocardial morphogenesis by determining endothelial cell identity and modulating trabecular growth and
coronary angiogenic signaling. We will test this hypothesis using multiple genetic and biochemical approaches.
Upon completion of this study, we will gain novel insights on the pathogenesis of LVNC.

Public health relevance
PROJECT NARRATIVE The etiology of left ventricular noncompaction cardiomyopathy (LVNC) is poorly understood despite becoming more frequently diagnosed. In this study, we will identify mechanisms at the cell and regulatory levels by which Zip8/Zn in the developing cardiac endothelial cells orchestrates myocardial morphogenesis (trabeculation and compaction). These new findings will help us to better understand the pathogenesis of LVNC and CHDs more broadly and give insights for future therapeutic strategies.